SBIR Phase I Topic 407 - Cloud-Based Software for the Cancer Research Data Commons.

Precision oncology offers great potential in improving cancer-related diagnosis and treatment. The Navipoint Platform provides state of the art tools, pipelines, and cloud-based resources, which will be extended and integrated with CRDC data and resources in order to enable “Collaborate in the Cloud” capabilities to help realize this promise. The product of this SBIR will be a prototype system demonstrating the integration between Navipoint and CRDC. The proposed approach includes the following: To develop, leverage and disseminate commercial analytical tools in the Navipoint bioinformatics analysis platform that can seamlessly integrate with, and fully leverage, CRDC resources in order to help drive new cancer discoveries for improved prevention, diagnosis and treatment. To build a prototype system that extends and integrates the Navipoint Platform with CRDC through adoption of the Data Commons Framework to support several cancer-specific analysis and multi-domain use-cases. And to perform a usability study with a cross-section of users to validate capabilities of the prototype system and document areas of improvement.